Examining uptake and use patterns of cigarettes and other nicotine delivery products among youth in countries with different regulatory environments: ITC Nicotine Product Youth and Young Adult Survey

SUMMARY/ABSTRACT
Youth and young adulthood are critical periods for tobacco use. For most of the past two decades, smoking
has steadily declined among young people in the US and other Western countries, including Canada (CA) and
England (EN). In contrast, nicotine vaping products (NVPs) have experienced rapid growth and are now the
most prevalent nicotine product used by youth and young adults. The long-term public health impact of NVP
use among young people is widely debated, including its impact on smoking behavior as either a `gateway' into
smoking or a means to `displace' cigarette use. The nicotine market is poised to diversify further with the
emergence of heated tobacco products (HTPs), such as Marlboro Heatsticks in the US, and novel oral nicotine
products. The extent to which these novel products appeal to young people and follow a similar trajectory as
NVPs represents a critical question. The policy environment is changing in response to the rapidly evolving
product market. A range of new nicotine and tobacco policies are in the process of being implemented in the
US, CA and EN, most of which are targeted at reducing use among young people. The different regulatory
approaches across countries creates a series of `natural experiments' in nicotine and tobacco policy, which can
be used to evaluate their impact on young people. The proposed study consists of repeated cross-sectional
surveys conducted annually with national samples of youth and young adults (aged 16-29) in the US, CA and
EN. The same methods and measures are used in all three countries to provide directly comparable estimates
over time. The study would expand the current focus of the International Tobacco Control Policy Evaluation
Project (ITC) Youth surveys to include young adults (20-29) and will build on the four annual surveys waves
conducted between 2017 and 2020. The study has three primary aims: 1) to examine international variations in
smoking, NVP, and HTP use among young people; 2) to examine the impact of national-level policies on
prevalence and patterns of smoking and vaping among young people; and 3) to examine the relative impact of
policies on youth versus adult smokers. Overall, the proposed Project is uniquely positioned to examine
changes in tobacco and nicotine use among young people during a critical period in which both the product
and policy landscape is rapidly evolving. The between-country design provides a unique framework for
assessing the impact of specific policies, as well as the emergence of novel HTPs and oral nicotine products.
Finally, Project 2 is well-positioned to examine broader contextual differences across countries, such as the
legalization of cannabis.

Public health relevance
PROJECT NARRATIVE Youth and young adults play a central role in the rapidly evolving tobacco and nicotine market. The current study will examine tobacco use, nicotine vaping products, and heated-tobacco products among youth and young adults in three countries with very different policy environments: the US, Canada, and England. The between-country design provides a unique framework for assessing the impact of specific policies, as well as the emergence of novel HTPs and oral nicotine products. Finally, the study is well-positioned to examine broader contextual differences across countries, such as the legalization of cannabis, with direct implications for the vaping and smoking among young people.